Shared Resource 12: Nutrient and Phytochemical Analytics (NPASR)

PROJECT SUMMARY – NUTRIENT AND PHYTOCHEMICAL ANALYTICS SHARED RESOURCE (NPASR)
The mission of the NPASR is to provide niche services supporting research with high quality assays for
biomarkers of tobacco exposure, specific nutrients, or a vast array of anti-cancer phytochemicals found in food
sources. NPASR primarily supports the Molecular Carcinogenesis and Chemoprevention (MCC) and the Cancer
Control (CC) Programs, which have robust research examining the role of diet and tobacco in cancer etiology,
prevention, and survivorship. The NPASR co-Directors are Drs. Steven Clinton, a translational researcher in
cancer prevention (interim co-Director, Senior Faculty Advisor; MCC co-Leader) and Devin Peterson, a senior
food science chemist in the College of Food, Agricultural, and Environmental Sciences. The Specific Aims of the
NPASR are to: 1) provide expert, leading-edge bioanalytical method development and quantitative analysis of
nutrients and bioactive phytochemicals in foodstuffs; 2) conduct targeted quantitative analysis of nutrients,
bioactive phytochemicals and their metabolites in biological samples generated from in vitro, in vivo and human
studies using HPLC-MS/MS techniques; and 3) perform untargeted metabolomics and lipidomics services for
cancer-related studies. NPASR technologies include state-of-the-art ultra-high performance liquid
chromatography (UHPLC), mass spectrometry (MS) and liquid chromatography triple quadrupole MS/MS (LC-
MS/MS). NPASR has added several new analytical capabilities during the current funding cycle including: 1) ion
mobility hardware facilitating a broad semi-quantitative lipidomics platform; 2) a second MS instrument to support
untargeted metabolomics and lipidomics demand; and 3) a state-of-the-art MS/MS for utmost sensitivity. During
the current funding cycle, the NPASR supported 49 publications (2 > 10 impact factor), 55 users, and 6 NCI
grants, including 1 P50, 3 R01s, 1 U19 and 1 U01, involving all five CCC programs. These efforts and
publications have contributed to defining biomarkers of exposure or intake, and provided novel insight into
phytochemical absorption, distribution, metabolism, and excretion. More recently, NPASR has expanded into
targeted and untargeted metabolomics supporting our understanding of individual cancer risk due to tobacco
exposure, nutrients, specific foods, and dietary patterns. To meet future demands of OSUCC Investigators
aligned with OSUCCC strategic priorities, NPASR will further support, for example, studies of metabolomic-
microbiome interactions, genetic determinants of metabolism and tobacco use biomarkers. During the next grant
cycle, lipidomics and bioactive lipid analytic capabilities will be expanded to meet the needs of a growing user
base of all five programs. The NPASR provides a critical service for CCC members evaluating foods, nutrients
and carcinogens that spans research disciplines from cell culture and experimental animal studies to human
trials and molecular epidemiology. The annual budget of the NPASR is $387,249, yet the CCSG request is
$74,239. As such, the NPASR leverages extensive institutional support and seeks only 19.2% support from
CCSG funds.